Probing and controlling chirality across scales using nanophotonic platforms

ABSTRACT
Chirality, the property of being non-superimposable on its mirror image, plays a pivotal role in biological
systems. Homochirality, the exclusive use of one chiral form, shapes the structure and function of vital
biomolecules like proteins and DNA. This uniform chirality raises profound questions about life’s nature and
origins. However, current research faces challenges in bridging molecular and cellular understanding. Existing
methods, while high in resolution, often lack the capacity to provide a comprehensive view at larger cellular
scales. Conversely, tools designed for cellular-to-tissue analysis typically overlook finer molecular details. This
gap hinders our full understanding and manipulation of chirality in complex biological contexts, highlighting the
need for versatile tools capable of comprehensively exploring chirality across these varying scales.
Central to this effort is the development of cutting-edge nanophotonic technologies tailored for probing and
manipulating chirality. These advancements will enable high-resolution, label-free analysis of molecular and
cellular chirality, potentially revolutionizing our comprehension of chirality in biological systems and impacting
drug development and disease treatment.
This research aims to provide groundbreaking insights into the interplay between molecular and cellular
chirality, specifically how they affect cellular functions and disease mechanisms. It will tackle key questions
about the fundamental connections between cellular and molecular chirality, define and measure molecular
chirality at extremely low concentrations, and explore how altering cellular chirality could impact molecular-
level mechanisms and cellular functions. The anticipated outcomes include the creation of novel diagnostic
tools, safer chiral drugs, and non-invasive treatment methods, significantly advancing chirality research and
bridging the divide between molecular intricacies and cellular complexity.

Public health relevance
PROJECT NARRATIVE Chirality, or left and right handedness, is a fundamental property in biology, spanning the molecular, cellular, tissue, and organ levels. Various degrees of chirality have been observed separately at these levels, but they haven’t been connected across scales. This MIRA ESI proposal will create nanophotonic tools to fill the gap between these levels, allowing us to probe, image, and ultimately control chirality from single molecular to cellular levels.